A New-Generation Lipid-Lowering and Anti-Inflammatory siRNA Therapy for Atherosclerosis

ABSTRACT
High levels of lipids, such as cholesterol, are a major risk factor of development of atherosclerotic cardiovascular
disease (ASCVD), which promote plaque formation inside arteries. Despite the success of current lipid-lowering
therapies (e.g., statins and PCSK9 inhibitors), ASCVD remains one leading cause of mortality. This may be due
to the lack of effective and safe strategies that can concurrently reduce cholesterol synthesis in the liver and curb
arterial inflammation in the atherosclerotic lesion. The long-term objective of this project is to develop a new lipid-
lowering and anti-inflammatory siRNA therapy for more effective treatment of ASCVD, based on i) the discovery
of new biological roles of Epsin endocytic adaptor proteins in hyperlipidemia and atherosclerosis by Dr. Chen
(MPI) and ii) the development of long-acting, dual tissues-targeting siRNA lipid nanoparticles (LNPs) by Dr. Shi
(MPI). We recently revealed that Epsins regulate lipid metabolism and transport in atherosclerotic macrophages,
and that silencing macrophage Epsins leads to reduction of arterial inflammation and atherosclerotic plaque size.
In new preliminary studies, we also discovered that Epsins in liver hepatocytes contribute to hyperlipidemia by
promoting cholesterol synthesis and reducing low-density lipoprotein cholesterol (LDL-C) clearance. Thus, we
expect that co-targeting of Epsins in both the liver and atherosclerotic lesion will effectively restrict hyperlipidemia
and arterial inflammation in atherosclerosis. In parallel, we have lately developed a novel LNP platform that can
dramatically prolong the duration of efficient siRNA silencing after a single intravenous injection, as compared to
traditional siRNA LNPs. By further engineering our new siRNA LNPs, we can simultaneously silence Epsins in
the atherosclerotic plaque and liver. In light of these promising data, we hypothesize that our long-acting siRNA
LNP platform for dual tissues-targeting of Epsins could lead to development of a new, more potent lipid-lowering
and anti-inflammatory therapy for ASCVD. Here, we aim to i) further optimize and understand the long-acting
siRNA LNPs; ii) tune the siRNA LNP surface chemistry for sufficient co-targeting of the liver hepatocytes and
lesional macrophages in vivo; and iii) systematically evaluate the efficacy and safety of our siEpsins LNPs in
various mouse and rabbit models of atherosclerosis. The successful completion of this MPI project could facilitate
the development of next-generation therapeutics for ASCVD.

Public health relevance
PROJECT NARRATIVE Despite the success of lipid-lowering therapies, atherosclerotic cardiovascular disease remains a leading cause of mortality in the USA. The next-generation, more potent therapy for atherosclerosis may need to concurrently reduce cholesterol synthesis in the liver and curb arterial inflammation in the atherosclerotic lesion. The goal of this project is thus to develop a new lipid-lowering and anti-inflammatory therapy for atherosclerosis by silencing a common target in both the liver and atherosclerotic tissue.